Engineered Matrices with Electrical and Chemical Stimulation for Peripheral Nerve Repair

Project Summary/Abstract
Peripheral nerve injuries (PNI) affect millions of people in the US, and PNI with large gaps require surgical repair.
Although biological and synthetic grafts are widely used to repair PNI with large gaps, they both can suffer from
suboptimal clinical outcomes. Autografts are the gold standard treatment but are limited by availability and defect
repair size, while synthetic grafts have poor biodegradability, strength, bioactivity, and functionality. Thus, the
long-term objective of this proposal is to engineer grafts with enhanced large-gap nerve regeneration capabilities.
Physical and chemical stimulation can enhance nerve regeneration responses, thus, incorporating these
modalities into engineered grafts may address some current treatment limitations. Electrical stimulation (ES) can
enhance nerve conduction, neurotrophin release, and functional recovery of nerve crush injuries, but these
benefits have not been established for large-gap PNI. Chemical stimulation using 4-aminopyridine (4-AP; a
potassium channel blocker) appears similar to ES in its effects on neurons and can enhance crush PNI repair,
yet may act synergistically with ES. Implementing these physical and chemical cues for effective large-gap PNI
repair will require surgical insertion of an electrically conductive scaffold with appropriate mechanical strength,
degradation, conductivity, and pore properties. This proposal aims to deliver 4-AP and ES via novel,
biodegradable, ionically conducting (IC) chitosan scaffolds and hybrid engineered nerve allografts to repair large-
gap nerve defects. Bioengineered IC scaffolds with 4-AP can increase neurotrophin release in vitro and enhance
myelination of large-gap PNI in vivo in early-stage repair. Preliminary studies revealed that combined application
of 4-AP and ES reduced fiber capsule thickness around subcutaneously implanted scaffolds and increased in
vitro neurotrophin expression compared to 4-AP or ES alone. This suggests combining 4-AP and ES improves
functionality, biocompatibility, and positive immune responses. Therefore, it was hypothesized that IC scaffolds
combined with chemical and electrical cues will modulate cell-material interactions to enhance axon regeneration
rate and functional recovery comparable to autografts. This will be tested in three Specific Aims: 1) Develop and
characterize IC scaffolds with variations in 4-AP release rate, conductivity, and biodegradation; 2) Assess human
and rat Schwann cell responses to IC scaffolds with 4-AP and/or ES in vitro to model in vivo responses and
future interventions; and 3) Test safety and efficacy of engineered scaffolds and allografts with 4-AP +/- ES in a
critical-sized sciatic nerve defect. Engineered repair of large-gap PNI using bioactive electrical and chemical
cues will broadly impact the field. These studies will bridge the knowledge gap between the complex ES-
mediated cell-material interaction microenvironment and poorly studied underlying regeneration pathways.
These findings may improve the treatment of nerve defects, and inform exploratory work on regenerative
strategies for innervation in other musculoskeletal tissues.

Public health relevance
Project Narrative Every year, over half a million Americans suffer from large-gap peripheral nerve injuries that require surgical treatments with neural grafts or engineered graft substitutes, but these treatments suffer from limited availability and efficacy. Our objective is to address these issues by developing novel ionically conductive biodegradable scaffolds for reliable electrical and chemical stimulation to enhance the regeneration of large-gap nerve injuries. By bridging the knowledge gap between how chemical and electrical stimulation influence cell-material interactions and poorly studied nerve regeneration pathways, this project has the potential to significantly enhance large-gap nerve regeneration and functional recovery, ultimately benefitting patients suffering from peripheral nerve injuries.